California National Primate Research Center

OVERALL: CALIFORNIA NATIONAL PRIMATE RESEARCH CENTER
ABSTRACT
The California National Primate Research Center (CNPRC), located at the University of California, Davis,
requests funds to renew the base operating grant #P51-OD011107 for the next five-year period (May 1, 2023
through April 30, 2028). Currently in the 60th year of operation, the CNPRC serves a range of NIH-supported
investigators and industry partners nationwide. From inception through the current year, the CNPRC has been
highly responsive to the research community by providing high quality animals, facilities, tools, and services
driven by the intellectual infrastructure of the Core Scientists in the service of our Mission: “To improve human
health and quality of life through support of exceptional nonhuman primate research programs”. The
supplemental funds requested fits within the following Specific Aims: (1) Conduct state-of-the-art research and
scientifically contribute to the understanding and treatment of human disease with nonhuman primate models
across the life span, (2) Provide exceptional nonhuman primate expertise and services to investigators at the
local, regional, and national levels to advance NIH-supported research excellence, (3) Mentor and train the next
generation of translational investigators with nonhuman primate expertise and inform the public regarding the
importance and translational power of the nonhuman primate model, and (4) Ensure the highest standards of
responsible conduct of research and animal care. We will continue to emphasize team science aimed at major
human health problems across the lifespan, with the goal of moving beyond traditional interdisciplinary efforts to
true convergence on the research problems being addressed. Support is requested for Administrative Services
(Administration and Operations Services, Director’s Office, Information Technology Services), Alterations and
Renovations (Facilities Improvement), Colony Management Unit (Anatomic and Clinical Pathology Services,
Animal Care and Research Services, BioBehavioral Assessment, Genetics Management Services National
Institute on Aging Colony, Population and Behavioral Health Services, and Primate Medicine Services), Service
Cores (Flow Cytometry, Inhalation Exposure, Multimodal Imaging, Primate Assay Laboratory), Scientific
Research Units (Cardiorespiratory Diseases, Infectious Diseases, Neuroscience and Behavior, and
Reproductive Sciences and Regenerative Medicine), Outreach/Public Information Office, and the Pilot Research
Program. We are committed to developing and providing a wide range of research opportunities that maximize
use of the nonhuman primate model to improve human health. The institutional commitment from UC Davis to
the CNPRC is outstanding and will continue to facilitate our role in moving nonhuman primate research into the
next era of translational biomedical research.

Public health relevance
OVERALL: CALIFORNIA NATIONAL PRIMATE RESEARCH CENTER PROJECT NARRATIVE The California National Primate Research Center is an established national resource that has as a primary mission to improve human health and quality of life through support of exceptional nonhuman primate research programs that advance our knowledge of the causes, preventions, treatments, and cures of debilitating diseases. This mission is pursued through robust and well-developed on-site research programs, facilities, and expertise that are significantly augmented by collaborative programs that serve the greater biomedical research community. We are particularly committed to understanding health and diseases across the entire lifespan.